Extending and Maintaining the GenX Exposure Study

Project Summary/Abstract
The overarching goal of the GenX Cohort Study is to answer community questions about the potential health
effects of GenX and other per- and polyfluoroalkyl substances (PFAS). The GenX Cohort Study represents a
unique opportunity to understand the impacts of PFAS throughout the Cape Fear River Basin (~ 9,000 square
miles and 1 million residents). The central goal for this proposal is to provide a framework to strengthen and
maintain the GenX Cohort Study infrastructure so that we can continue to provide timely information to
impacted communities. In 2020, we were funded to create a community-based cohort of residents from the
lower Cape Fear River Region (New Hanover and Brunswick Counties), Fayetteville, and Pittsboro as part of
the NC State Superfund Center. A total of 1,091 individuals ages 6 and older were recruited; they provided
blood samples for analysis of PFAS and clinical outcomes (lipids, thyroid hormones, and metabolic panel).
With this grant, we will enhance our community engagement to ensure long term participation in the study. We
will prepare materials in Spanish and maintain a Spanish language website. In efforts to maintain interest in the
study, we will expand our community engagement throughout the region with the assistance of community
organizers and local NGOs focusing on water and environmental protection. We will also build the
infrastructure for the cohort by strengthening the coordinating center and data and specimen management
activities. We will continue cohort follow up for another five years and work to build a more inclusive workforce
in environmental health and epidemiology.

Public health relevance
Project Narrative This project will provide infrastructure support for data and specimen management to the GenX Cohort Study, a prospective study designed to follow 1100 people who live in the Cape Fear River Basin of North Carolina and who were exposed to PFAS (per- and polyfluoroalkyl substances) through their drinking water. We will enhance our community engagement activities to reach diverse audiences within the basin including Black and Latinx residents.